Training and Education

Training Component Abstract
The overall goal of the Equity in Maternal and Birthing outcomes and Reproductive
Health through Community Engagement (EMBRACE) Center Training Component is to promote
training and build capacity of the community of people involved in the collective care of the
reproductive, sexual and perinatal health of Black populations and other populations who are
oppressed, excluded, and under-represented. The overarching goal will be achieved through
the following aims: Aim 1: Mentoring. Promote success of early stage community-engaged
reproductive and perinatal health equity investigators in multiple disciplines across the training
continuum, including early career faculty, postdoctoral fellows, and predoctoral students,
through robust support by a team of academic, clinical, and community mentors; and enhance
mentorship and promote institutional connectiveness for reproductive and perinatal health equity
researchers who are underrepresented in academic medicine or the health sciences through
rigorous career development in a supportive, collegial environment through a variety of
structured interactions. Aim 2: Research Enrichment, Training, and Capacity Building.
Provide reproductive and perinatal health equity research, community-engaged research, public
health practice, data transparency, and communication training and support for early career
scientists and community health partners through an enrichment program including a pilot
funding program, research program support, support for scientific and public health conference
registration and travel, educational sessions, seminars, and research forums, and community
outreach. Aim 3: Community Integration. Create and empathize community-based training
that is focused on strengthening the reproductive and perinatal health workforce. Aim 4:
Reproductive Health Justice Training. Promote equitable, high-quality reproductive and
perinatal health supports and care through provision of reproductive justice, anti-racism, anti-
oppression, and humanity-centered training to support a culturally responsive workforce of
clinicians, researchers, and community and organizational leaders.

Public health relevance
Training Component Narrative The overall goals of the Equity in Maternal and Birthing outcomes and Reproductive Health through Community Engagement (EMBRACE) Center training, capacity building, and education program are to: 1) support training and professional development of community- partnered reproductive and perinatal health researchers; and 2) build and provide high quality training for a community-informed care and public health practice workforce focused on reproductive and perinatal health equity and elimination of health disparities. The training program will serve as a backbone of the EMBRACE Center's thematic focus to improve maternal and reproductive health for Black populations.